Phosphoinositide Signaling and Optic Nerve Regeneration

ABSTRACT
Background and Innovation: Glaucomatous optic neuropathy is a primary cause of irreversible blindness
among veterans. Reducing eye pressure remains the only treatment for glaucoma patients experiencing vision
loss. The gradual loss of retinal ganglion cells leads to a progressive decline in vision and the potential for
permanent blindness. In our previous research phase, we successfully established an innovative mouse model
of glaucoma, silicone oil-induced ocular hypertension. Using calcium indicators expressed exclusively in retinal
ganglion cells, we also developed methods to detect functional changes in ganglion cells under stress.
Preliminary data support the involvement of phosphoinositide metabolism signaling pathways. INPP5K is an
inositol 5-phosphatase that dephosphorylates PIP3 and regulates ER structure as well as ER stress. We also
have shown that the ER stress pathway is involved in optic nerve regeneration in mouse models of glaucoma.
We hypothesize that targeting both phosphoinositide and endoplasmic reticulum stress pathways will enhance
protein synthesis, facilitate axon regeneration, and ultimately lead to more significant axon regeneration in the
central nervous system. Our proposal aims to investigate whether targeting both INPP5K and ER stress
responses will enhance optic nerve regeneration.
Significance and Impact to Veterans Healthcare: Glaucoma is a blinding condition that affects over 285,000
Veterans. Currently, all glaucoma treatments can only slow down the disease, with no effective means to
regenerate the optic nerve. By determining the therapeutic potential of the phosphoinositide pathways, our
research will contribute to developing innovative therapeutic strategies to promote functional recovery. This, in
turn, will aid in the discovery of new therapies for open-angle and other forms of glaucoma for our veteran
patients. Our proposal addresses the VHA/ORD research priority for increasing the impact of VA research.
Ultimately, the knowledge gained from this project will develop novel therapeutic compounds to benefit
veterans suffering from vision loss.
Path to translation/implementation: The pathway to translation and implementation involves enabling the
translation of small molecule-based treatments for optic nerve regeneration from the laboratory setting to
clinical use. Initially, these treatments will undergo rigorous evaluation in animal models to assess their
efficacy, safety, and potential side effects. Successful candidates will progress towards clinical trials; we aim to
bridge the gap between experimental findings and tangible therapeutic interventions, ultimately offering hope to
veterans suffering from glaucoma and other forms of optic neuropathies.

Public health relevance
NARRATIVE Glaucoma is a leading cause of irreversible blindness worldwide that affects over 285,000 US veterans. Despite lowering of eye pressure, patients often suffer progressive vision loss leading to blindness. Here, we propose novel pathways to help preserve optic nerve survival by targeting phosphoinositide signaling, which will ultimately lead to new treatments for VA patients with glaucoma.